Investigation of heterogeneity in cancer cell proliferation - COVID extension request

Project Summary/Abstract
Lung adenocarcinoma is a complex disease with high prevalence and mortality. The low survival rate is worsened
by the long-term ineffectiveness of many cancer therapeutics, which eliminate most but not all of the cancer cells
in a tumor. Cellular phenotypic diversity is an important feature of cancer for the fields of basic biology and
medicine, but the mechanisms by which tumors establish and maintain this diversity is poorly understood. One
key aspect of tumor phenotypic diversity is proliferative heterogeneity: the presence of cancer cells that exist in
proliferative states ranging from quiescence to persistent cell division. The Wnt pathway is a potentially important
driver of proliferative heterogeneity, as it is central to the maintenance of a highly proliferative, cancer stem cell-
like state in lung adenocarcinoma. To interrogate proliferative heterogeneity in an unbiased manner, we have
established a novel genetically engineered mouse model of lung adenocarcinoma that enable us to identify
different tumor subpopulations based on proliferative state. We will use this mouse model to isolate highly
proliferative and persistently quiescent cancer cells, which we will then interrogate functionally and
transcriptionally. In these experiments we seek to identify the impact of a cell’s proliferative state on its
tumorigenic capacity (Aim 1). We will also characterize the mechanisms by which distinct proliferative states are
established and maintained. In particular, we will focus on the Wnt pathway to identify the role of individual Wnt
ligands in driving distinct proliferative states. The goal of these experiments is to determine the impact of targeting
Wnt signaling on specific proliferative states and to identify additional cell states with robust growth potential
(Aim 2). Lung cancer has a poor prognosis, but basic science research that improves the understanding of lung
tumor heterogeneity can lead to significant advancements in how patients are treated. Further elucidating the
phenotypic diversity that causes disease relapses may advance our ability to control tumor behavior and increase
the ability of existing cancer treatments to fully eradicate the disease through elimination of resistant cell states.

Public health relevance
Project Narrative Heterogeneity in cancer cells is a clinically important but poorly understood property of tumors that has the potential to explain tumor growth, treatment relapse, metastasis and other cancer behaviors. This proposal aims to characterize the heterogeneity of proliferating and quiescent cancer cell populations in lung adenocarcinoma and investigate the role of Wnt signaling in maintaining distinct proliferative states. Completion of this research plan will enhance our understanding of the mechanisms tumors use to develop cellular diversity, which may suggest strategies for improving cancer treatment.